Acute Use of Alcohol and Attentional Bias towards Suicide: An Experimental Test of the Attention-Allocation Model.

Abstract
Acute use of alcohol is associated with increased risk for suicide attempts and deaths. Theory suggests that
acute use of alcohol (AUA) may lead to increased attentional bias towards suicide-related cues, and thus
increased suicide risk, when negative mood states and suicide-related alcohol expectancies are salient
(Giancola, Josephs, Parrott, & Duke, 2010; Hufford, 2001; Josephs & Steele, 1990). However, no experiments
have tested these basic theoretical tenets. The current K23 pilot experiment will create the basis for a large-
scale test of these questions by first testing the feasibility of the study procedures and exploring effects among
the theory constructs. However, there is also a scarcity of data related to alcohol-facilitated suicide risk among
sexual minority people—a population with heightened risk for suicide compared to the general population. To
address this need, the proposed administrative supplement will allow for more intentional recruitment of sexual
minority people for the parent K23 project. Through collaboration with community partners, we will recruit 60
sexual minority individuals to increase their representation in the parent study. This work will be critical for future
studies, particularly alcohol administration experiments that assess the effects of AUA on cognitive, behavioral,
and emotional processes among sexual minority people.

Public health relevance
Project Narrative Acute use of alcohol is associated with an increased likelihood of suicidal ideation, attempts, and deaths; however, the mechanisms and conditions underlying these risks are not well understood. Additionally, sexual minority individuals are especially underrepresented in studies examining alcohol-facilitated suicide despite this community’s heightened risk for suicide. This administrative supplement will support the recruitment of sexual minority participants for the parent project, which will increase the generalizability of our findings to this population.